Neural Mechanisms that Underlie Eating in the Absence of Hunger

The rising prevalence of obesity throughout the world represents a major public health challenge for the
21st century. Although several new therapies seem likely to be approved, the most effective long-term treatments
for obesity are surgical, while current behavioral interventions focused on diet fail 90% of the time. A major
challenge in dieting is controlling food intake in the face of our rich sensory environment that includes many
sensory cues that have become associated with foods. These sensory cues elicit cravings and food-seeking
behavior even in the absence of physiologic need. The amygdala and related brain structures such as
orbitofrontal cortex mediate associative learning processes, and the processing of sensory cues in these areas
can modulate food consumption. However, the precise neural circuit mechanisms through which cues modulated
consumption remain poorly understood, and their interaction with homeostatic signals that limit food intake are
completely unknown. Indeed, studying how sensory cues promote feeding in circumstances when homeostatic
signals limit consumption has been difficult to study. Here, we propose to study the circuits and mechanism by
which sensory cues drive feeding behavior in the absence of hunger, i.e. during acute satiety following a meal
and when mice have been overfed to induce hypophagia. We train mice to associate specific sensory cues, e.g.
a tone, with rewarding foods, and later use the cue to increase food consumption. We use this behavioral
paradigm to test the ability of sensory cues to challenge the return to baseline body weight that occurs following
over-feeding, and also to test whether this leads to a higher body weight set-point. We will use state-of-the art
neuroscience tools including viral-mediated circuit tracing, activity-dependent recombinant expression of genes,
calcium imaging, whole-brain histology, and optogenetics to test the hypothesis that amygdala-related circuits
drive cue-induced feeding behaviors via the lateral hypothalamus, and can drive feeding during the absence of
hunger. In Aim 1, we will express calcium indicators in amygdala related circuits to study the encoding of sensory
stimuli during cue-induced feeding. We then use optogenetics to test whether these areas are necessary and
sufficient to modulate cue-induced feeding behaviors. In Aim 2, we will combine cue-induced feeding with
overfeeding to test the ability of cue-induced feeding to cause weight gain, and circuit-elements involved in this
process. Understanding the neural mechanisms whereby sensory cues can drive feeding-behavior in the
absence of physiologic need will help us understand environmental contributors to obesity, and why long-term
success in dieting and weight-loss is rare. These studies may ultimately help identify targets for treatment and
prevention of obesity.

Public health relevance
Sights, smells and tastes associated with foods can be powerful drivers of food seeking behavior and consumption, even in the absence of hunger or physiologic need. We believe this phenomenon is a significant contributor to obesity, but the brain circuits and mechanisms underlying the phenomenon are poorly understood. This project uses cutting-edge neuroscience techniques to identify the neural circuits and mechanisms whereby sensory cues can drive consumption in the absence of hunger, and therefore, has the potential to identify new therapeutic targets for the treatment of obesity.